The uptake and real-world effectiveness of emerging respiratory syncytial virus maternal vaccines and monoclonal antibodies on short- and long-term respiratory morbidities

PROJECT SUMMARY / ABSTRACT
Respiratory syncytial virus (RSV) is one of the most common respiratory viruses resulting in significant
morbidity and mortality in infants and young children globally. Recent approvals of the world's first maternal
vaccine and infant extended half-life monoclonal antibody mean that for the first time, all infants born in the US
in 2023 and later will have immunization options for protection from RSV-associated severe illness. The two
currently available prevention products differ in target recipients, timing of administration, biologic mechanism
of action, and duration of infant protection. As these products have become part of recommended maternal
and infant vaccine schedules, key questions needed to inform policy include determining: 1) the real-world
comparative effectiveness, 2) the cost-effectiveness of these products, 3) safety of maternal vaccine, and 4)
impact on other acute and long-term respiratory outcomes. To address these questions, we propose to
assemble a population of over 735,000 mother-child dyads including infants born 2023-2029 utilizing the
diverse populations represented by the Tennessee Medicaid Program and Department of Defense Military
Health System. The overarching objectives are to determine optimal RSV prevention strategy(ies) taking
into consideration infant date of birth relative to RSV circulation, infant risk for RSV LRTI, maternal-
child characteristics, and the effectiveness and cost-effectiveness of RSV prevention products in
reducing the risk of RSV LRTI, other acute respiratory illness, and later childhood all-cause respiratory
morbidity. We will determine the uptake, adherence to policy recommendations, and characteristics of those
who receive the approved RSV prevention products (Aim 1), the real-world effectiveness and comparative
effectiveness in reducing the risk and severity of RSV LRTI and other acute respiratory morbidities (Aim 2), the
effectiveness on reducing later childhood all-cause respiratory morbidity (Aim 3), and the cost-effectiveness in
reducing RSV LRTI and childhood all-cause respiratory morbidity (Aim 4) of these RSV prevention products.
Socioeconomic associated health disparities at the individual and neighborhood levels in vaccine uptake (Aim
1) and effectiveness (Aims 2 & 3) will be determined. With supply chain limitations affecting the availability of
infant extended half-life monoclonal antibody, the 2023-2024 respiratory season presents a unique opportunity
to evaluate these disparities in the setting of the initiation of a large nationwide medical intervention. Results of
the study will inform public health expectations and policy recommendations for RSV maternal vaccines and
extended half-life monoclonal antibodies, and more importantly, identify and quantify any value-added long-
term benefits of RSV LRTI prevention during infancy on later childhood respiratory morbidity. We anticipate
that this will in turn increase public acceptability, promote uptake of RSV prevention products in the US, and
provide data to support the acute and longer-term benefits of these prevention products worldwide, promote
uptake of these products worldwide and particularly in low- and middle-income countries.

Public health relevance
PROJECT NARRATIVE Respiratory syncytial virus (RSV) is a common respiratory virus infecting infants and young children, and the most common cause of infant hospitalization in the US and of respiratory mortality worldwide. After more than sixty years in development, we now have the world's first RSV vaccine and extended half-life monoclonal antibody, and for the first time, all infants born in 2023 and later could be offered protection from RSV- associated severe illness. We will evaluate how, when, and to whom these products are administered, providing key data on the comparative short- and long-term protection and costs, important data to guide individualized use, and to inform worldwide policies regarding the use of these RSV prevention products.